Understanding the Adoption and Impact of New Risk Assessment Technologies in Prostate Cancer Care

PROJECT SUMMARY/ABSTRACT
New, expensive risk assessment technologies are rapidly being integrated into the care of patients with
prostate cancer. Advanced imaging (prostate MRI) and genomic tests have been developed and are now
deployed to overcome a central challenge in the management of the disease: a remarkably high prevalence,
yet comparatively low lethality. For decades, uncertainty regarding the true nature of a patient's prostate
cancer has led to the unnecessary treatment of indolent (`low-risk') disease in millions of men resulting in
lasting side-effects for many. By improving the ability to distinguish low-risk from aggressive cancers, it is
believed that more accurate tools will allow many patients to safely observe low-risk cancers with careful
monitoring (active surveillance). Although these two ascendant technologies have been evaluated in controlled
studies, no real-world evidence is available to understand their impact. Specifically, it is not known which
patients are receiving testing, whether use of these technologies reduces unnecessary treatment, or how
patients and doctors perceive of their benefit. To address these knowledge gaps, we aim to comprehensively
understand how prostate MRI and genomic testing impact the management of prostate cancer. We will
accomplish this goal through two complementary phases aimed at: (1) defining how adoption of prostate MRI
and/or genomic testing has affected clinical management, and (2) understanding how patients and physicians
perceive of these tools during decision-making. We hypothesize that whether or not prostate MRI and/or
genomic testing are performed is dependent on the doctor that they see, but that testing is associated with
lower rates of treatment. We will use large national datasets of men with prostate cancer and examine the
adoption of prostate MRI and/or genomic testing, and whether the use of these technologies is associated with
increased use of observation versus treatment. To learn how these tools are used in decision-making for low-
risk prostate cancer, we will conduct in-depth interviews of both patients with prostate cancer and doctors who
diagnose and treat the disease. The results from this research will shape efforts to improve how these tools are
used in the management of men with prostate cancer. Candidate: this proposal supports the professional
development of the candidate as an independent, patient-oriented surgeon-investigator focusing on improving
prostate cancer care. This application is centered around a rigorous training program including coursework that
leverages the candidate's background as a prostate cancer surgeon and clinical outcomes researcher whose
prior work has focused on risk assessment technologies and active surveillance of low-risk prostate cancer.
The applicant will build upon his expertise by earning a Masters in Health Science from Yale University, and
develop a skill set in qualitative research and implementation science. The completion of this mentored training
award will position the candidate to develop and test a framework for refining the use of new technologies for
patients with prostate cancer, potentially reducing over-treatment and cost.

Public health relevance
PROJECT NARRATIVE New technologies have been deployed to improve the accuracy of initial risk assessment for men who have been diagnosed with prostate cancer, and are heralded to facilitate reductions in high treatment rates for patients with non-aggressive cancers. Although evidence from clinical trials supports a benefit of the most commonly used technologies—prostate MRI and genomic testing—it is not known how they have been integrated in real-world practice settings, how their use affects management decisions, or how patients and their doctors integrate their results during decision-making. To address these fundamental knowledge gaps we will perform a multi-method study to comprehensively understand the adoption and real-world impact of prostate MRI and genomic profiling using nationally representative administrative claims data as well as an in- depth qualitative interviews of patient and physician end-users of these technologies.